NIDA Epidemiology Training Program

Substance use disorders remain among the leading causes of disability and premature death in the
world, with rates remaining stubbornly high. Training with a rigorous methodological basis and a
breadth of course work and research experiences is necessary to develop the next generation of
scientists able to lead efforts to reduce the public health burden of substance use disorders.
Accordingly, this renewal application seeks to extend the pre- and post-doctoral Drug Dependence
Epidemiology Training Program, one of NIDA’s oldest continuously funded training grants now
entering its 25th year in the Department of Mental Health at the Johns Hopkins Bloomberg School of
Public Health. The goal of this training program is to produce the next generation of substance use
epidemiologists who can address this need by: conducting research that will advance our
understanding of the environmental and biological components of the etiology and natural history of
substance use; developing, implementing, and evaluating interventions to prevent and control
substance use; and critically examining substance abuse services, treatment and trends to improve
substance abuse outcomes including HIV-related risk. We will train substance use epidemiologists
who are able to tackle these challenges by emphasizing four focal areas in this iteration: (1)
social and environmental factors; (2) genetic and biological factors; (3) treatment and services;
(4) emerging trends. This training program will capitalize on the interdisciplinary resources at
Johns Hopkins University to provide trainees with the skills and experiences needed to lead
multi-disciplinary research that takes advantage of these emerging opportunities and promotes
overall health and well being of communities. Trainees will achieve this through a rigorous program
of coursework, research apprenticeships, and integrative activities that provide a solid foundation
in the core proficiencies of substance use epidemiology. The program will include 7 predoctoral
students and 7 postdoctoral fellows who are supported by an experienced group of 12 Core Faculty
and 36 Affiliate Faculty. The trainees will be prepared to assume leadership positions in academia
carrying out substance use epidemiology and HIV research typically as faculty in Schools of Public
Health or Medicine, in government formulating research priorities and substance abuse policy at the
local, state, national, and international levels, in private industry conducting applied research
for pharmaceutical companies, and in non- profit agencies or non- governmental organizations
advocating for those with substance use disorders.

Public health relevance
The Drug Dependence Epidemiology Training (DDET) Program is among the oldest continuously funded NIDA training programs and is designed to increase the number and quality of expert substance use epidemiologists, with special focus on HIV and advanced statistical methods to inform the design and analysis of epidemiologic studies and to close the research-to-practice gap. The proposed renewal takes advantage of the rich research and training resources available at Johns Hopkins University to build on our success training students in the core disciplines of epidemiology and biostatistics, while incorporating new types of data and recognizing emerging trends in substance use, such as the opioid epidemic.